Integrative Curation of Clinically Relevant Variants in X-Linked Inherited Retinal Disease Genes

Abstract
Inherited retinal diseases (IRD) are a major cause of early-onset blindness, profoundly affecting millions of
patients. Given the clinical and genetic heterogeneity of IRD, targeted gene therapy is emerging as the principle
effective approach for treating the disease with many clinical trials currently underway. Molecular diagnosis is
the required first step allowing patients to access and benefit from these emerging therapies.
In 2021, coordinating with the ClinGen Ocular Clinical Domain Working Group committee, we established a new
variant curation expert panel (VCEP) that is developing variant curation specifications for definitively assigned
disease-gene pairs and curating expert assessment of variants in X-linked IRD genes. Here we propose to scale
up our variant curation effort while expanding the scope of our initial application which is addressing the variant
curation specifications for seven genes (RPGR, CHM, RS1, RP2, OFD1, NDP, and CACNA1F) to include three
additional X-linked IRD genes (NYX, OPN1LW, OPN1MW) and provide ClinGen FDA approved assessment of
more variants in each gene by applying our specifications. Collectively, mutations in these genes account for
>15% of IRD patients with clinical trials ongoing for three genes. Our committed and engaged distinguished
panel of scientists from across the world have diverse expertise: practicing ophthalmologic physicians, clinical
diagnostic laboratory directors, and world-leading researchers studying the function of the X-linked IRD genes
in the clinical and research domains. These experts bring complementary knowledge and resources to this effort
including functional laboratory assays to assess the impact of patient variants, clinical trials for gene-based
treatments, and collections of patient samples with sequenced variants and a detailed clinical and family history.
Together with dedicated bioinformatics, curatorial, and administrative support, the X-linked IRD Variant Curation
Panel will continue to deploy the FDA approved ClinGen infrastructure tools and processes in combination with
the supportive resources we propose to collect, organize, and provide to the panel to develop rule specifications
for new genes and provide ongoing curation of X-linked IRD gene variants. With our panel and team of
coordinated curation volunteers, we will curate and expertly assess the variants in these genes. The products of
this effort will be two-fold. First, robust, tested specifications that can be applied to assess new variants in the
genes including new specifications specific for the proposed new genes and additional examples for the variety
of different X-linked IRD genes that can serve as models for other genes. And second, curated variants in the
X-linked IRD genes with three-star FDA registered (expert panel assessed) ratings in the ClinVar database that will
improve the assessment of de novo patient variants and enable treatments with gene-based therapies.

Public health relevance
Narrative Effective classification of gene variants associated with inherited retinal diseases is critical for accurate molecular diagnosis and is required to match patients to appropriate treatments to address blindness. Here we will develop disease- and gene-specific rules to modify official ACMG/AMP guidelines for variant interpretation and use these specifications to curate genomic variants found in clinical samples. This work will utilize NHGRI Clinical Genomics Resource (ClinGen) FDA approved processes, procedures, and informatics infrastructure to address X-linked inherited retinal disease genes including CACNA1F, CHM, OFD1, NDP, NYX, OPN1LW, OPN1MW, RPGR, RP2, and RS1.